Localized SDF-1 mRNA nanoparticle delivery for treating erectile dysfunction.

PROJECT SUMMARY
About 18 million men in the U.S. are affected by erectile dysfunction (ED), and it is estimated to affect
322 million men worldwide by 2025. ED is caused by various conditions that perturb vascular, nervous and/or
hormonal systems, imposing profound negative impacts on quality of life and well-being of affected males.
Advent of oral formulations of phosphodiesterase type 5 inhibitors (e.g., Viagra®) has provided a breakthrough
in managing ED to a certain degree but are frequently ineffective due to underlying neurovascular dysfunction,
and often accompanies systemic side effects and undesired drug-drug interactions. To this end, a therapeutic
modality that can intervene the natural histology of the disease among a broader affected population is sorely
needed. We have recently discovered that human recombinant stromal cell-derived factor-1 (SDF-1) promotes
regeneration of penile vasculatures, nerves and muscles to restore erectile function in a rat model of ED. The
improvement was associated with increases in major pelvic ganglion neurons and growth factor expression,
upregulation of stem-cell associated genes and decrease in penile fibrosis. Importantly, SDF-1 targets a broad
array of repair mechanisms by acting directly on resident tissues and activating stem-cell associated repair
pathways to enhance the integrity of tissue architecture and functional response. However, protein-based
therapy requires multiple and frequent doses to meet the required therapeutic window, leading to economic
and compliance issues. This is of particular concern for SDF-1 due to its very short half-live, measured in
minutes. We thus propose here to develop mRNA-based SDF-1 therapy, with a particular focus on designing
nanoparticle-based platforms providing safety and efficient mRNA delivery to penile cells, for sustainable ED
treatment. Our interest lies in nanoparticles based on environmentally-sensitive cationic polymers that
gradually degrade in physiological environments to facilitate mRNA release, ideally in intracellular milieu, and
removal of carrier materials from body. Encouragingly, our pilot data demonstrates that at least four
nanoparticles based on our custom-synthesized polymers provide significantly enhanced reporter mRNA
expression in rodent penile tissues in vivo compared to a gold-standard polymeric delivery system. We note
that chemical variations of these polymers can further improve mRNA delivery characteristics, such as broader
tissue coverage and/or enhanced transfection efficiency. To this end, we will synthesize a panel of chemically-
distinct environmentally-sensitive polymers and extensive screen in vitro and in vivo to determine lead
candidates that provide highly efficiently and safe penile mRNA expression. The lead candidates will then be
used to package and deliver optimized SDF-1 mRNA into the injured penile tissues of a rat model of ED to
establish clinical relevance. Successful execution of the proposed studies would pave the way for clinical
development of novel mRNA-based therapy for treating patients with ED, particularly those poorly responsive
to current standard-of-care treatments.

Public health relevance
PROJECT NARRATIVE Erectile dysfunction (ED) imposes profoundly negative impacts on well-being of the affected males, particularly those with neurovascular defects (e.g., diabetes, hypertension, prostate cancer, etc.), but currently available treatments moderately manage the symptom at best. Encouragingly, we have discovered that a naturally- occurring biological agent, specifically stromal cell-derived factor-1 (SDF-1), possesses unique ability to potentially reverse the underlying cause of the disease. We thus propose here to develop novel SDF-1-based mRNA therapy for safe, sustainable and unprecedentedly curative treatment of ED.